Functional and Mechanistic Analysis of Mesenchymal Stem Cell Secretome to Ameliorate Ischemic Damage of Porcine Heart ex vivo and Human Myocardium

Heart transplantation is a key life-saving therapy for patients with end-stage heart failure. However, donor
hearts are in severely short supply, resulting in death of many transplantation candidates before a suitable donor
heart becomes available. Despite this, approximately 70% of cardiac allografts were rejected for transplantation
during 2019-2021; the majority do not meet acceptance criteria, including the limited acceptable time that the
heart experiences warm ischemia, which is longer with donation after circulatory death (DCD) compared to
donation after brain death, the traditional method. This time correlates with progression of myocardial
ischemia/reperfusion (I/R) injury. Ameliorating I/R injury, that occurs both during heart procurement and
transport, would improve preservation of graft function, expand the donor pool and increase access to heart
transplantation. Human adipose-derived stromal cells (hASC) are abundant, simple to isolate and expand rapidly
in vitro, and produce paracrine factors that improve many pathologies, including ischemia/reperfusion injury. In
the context of myocardial infarction, they improve myocardial function, inhibit apoptosis, and stimulate
angiogenesis. Pre-treatment of explanted hearts with hASC improves myocardial functional recovery following
acute I/R injury in an ex-vivo heart perfusion system. Similarly, pre-ischemic infusion of ASC-derived factors
(secretome, ASC-S) improved myocardial function during recovery from cold ischemia, and almost completely
preserved normal expression of myocardial genes governing mitochondrial processes. A media supplement,
B27, with many similarities to hASC-S, ameliorated mitochondrial metabolic problems associated with cold
ischemic exposure of both rodent hearts and human iPS-derived cardiomyocytes (hiPS-CM). Finally, both hASC-
S and B27 enhanced recovery of beating rate and velocity in hiPS-CM after DCD-like ischemia/reperfusion.
Accordingly, the hypothesis that hASC-secretome will ameliorate warm ischemia/reperfusion-induced
deterioration of adult human and pig heart slice cultures in vitro, and model donor hearts ex vivo, by
mechanisms mediated by soluble factors as well as exosomes, which limit damage to cardiomyocytes
by preserving mitochondrial energetics and mitigating reactive oxygen species production and
apoptosis will be tested. To do that, three specific aims will be employed:
Aim 1. Evaluate the protective effect of ASC-S on pig and human adult heart slices in long-term
culture in conditions modeling procurement and transport conditions of DCD hearts, and whether this
is best mediated by secretome, its components or B27. Slices of adult human or pig hearts exposed to warm
ischemia in vitro in the context of cardiac procurement will be incubated with either ASC-S, or ASC-S derived
exosomes, the exosome-free fraction or B27. Time and dose-dependent effects of treatments will be evaluated
on apoptosis, infarct area, beat recovery and markers of cell damage. The optimally performing preparation will
be studied in Aims 2 and 3.
Aim 2. Evaluate the protective effects of extracorporeal infusion of ASC-S or its component on normal
pig donor heart preservation during cold static storage following donation after circulatory death (DCD).
ASC-S or its components preservation of normal pig hearts ex vivo will be tested as a preclinical model of DCD
organ procurement and transport. Heart function will be assessed in a Langendorff preparation.
Aim 3. Establishment of the biochemical mechanisms by which ACS-S preserves cardiomyocyte
bioenergetics Using a comprehensive suite of biochemical diagnostics (physiological assessment of OXPHOS
conductance via high-resolution respirometry, dehydrogenase activity, mitochondrial membrane potential,
hydrogen peroxide emission and scavenging and activity of mitochondrial enzymes), we will define the
biochemical mechanisms for improved cardiomyocyte energetics with ASC-S treatment in human and pig heart
slice cultures and porcine hearts.

Public health relevance
Approximately 5% of Veterans have heart failure and between 2014 and 2018 14.5% of those died because of it. Heart transplant is the life-saving cure for end-stage heart failure, but there are not enough hearts for the people who need them. This is often because the heart accumulates damage from lack of blood supply the longer it is out of the donor before being placed in the recipient, so it cannot be transplanted successfully. If this damage could be lessened there would be more hearts for transplant. A type of cell isolated from fat can be cultured and the factors they produce reduces this kind of damage. This study aims to test whether those factors, a particular part of the secretions or a very similar commercially available compound, could be used to treat hearts and reduce the amount of this damage They will be tested in models of a recent method to obtain hearts called donation after circulatory death during which hearts get more damaged than the traditional donation after brain death, thus potentially greatly increasing the number of suitable hearts for transplantation.